Imaging zinc secretion from the exocrine pancreas for the early diagnosis of pancreatic adenocarcinoma with MRI

PROJECT SUMMARY/ABSTRACT
This proposal aims to use noninvasive molecular magnetic resonance (MR) imaging of pancreatic zinc content
and secretion to detect pancreatic intraepithelial neoplasia (PanIN), as early pre-malignant pancreatic ductal
adenocarcinoma (PDAC) lesions. It is estimated that 55,440 people in the US will be diagnosed with pancreatic cancer
and 45,750 people will succumb to the disease in 2019. Current diagnostic techniques include the use of imaging to
localize a lesion and invasive biopsy sampling to stage the cancer and obtain molecular and cellular information from
the tumor. Once diagnosed, there are limited treatment options since symptomatic patients will likely already have
advanced stage PDAC. Therefore, there is a need to detect PDAC lesions early and in a non-invasive manner. It is
known that zinc is stored in zymogen granules in acinar cells at high levels and that zinc homeostasis is uniquely
dysregulated in PDAC. We have successfully demonstrated that MR imaging with gadolinium (Gd)-based zinc sensors
can report on zinc release from exocrine pancreatic tissue as a response to caerulein stimulation. In this proposal we
will evaluate a panel of secretagogues, which are chemical compounds known to stimulate the secretion of zinc from
ductal and/or acinar cells in the exocrine pancreas, to optimize their ability to generate zinc flux detectable with our
molecular MR probe. I will then use this cell-specific metabolic zinc imaging technique to noninvasively quantify the
zinc homeostatic dysregulation in pancreatic cancer mouse models by MRI. Elucidating the role of zinc homeostasis in
the development of pancreatic adenocarcinoma by non-invasively measuring zinc release from acinar and ductal cells as
a response to their natural secretagogues will allow us to identify biomarkers that report on molecular
transformations early in the disease. This in turn could then enable patients to obtain a diagnosis at an early stage and
thus have access to more effective therapies and curative surgical options.
The short-term goal of this project is to optimize and characterize the stimulated zinc secretion in the
exocrine pancreas and its detection in vivo with molecular MRI to identify early malignant transformations in PDAC, in
doing so I will obtain the training from my advisory committee, who are experts in the field of pancreatic cancer
molecular pathogenesis, histopathology, surgery, and radiology. Attaining my short-term goal will enable me to obtain
expertise in the following areas: 1) Clinical pathology techniques for diagnosis of pancreatic adenocarcinoma. 2)
Biomarker identification and validation. 3) Metabolic implications of zinc homeostasis in PDAC pathogenesis. This
project will also allow me to generate data that will enhance my probability of success in obtaining independent NIH
grant support. With the skills and knowledge obtained as a result of the research and training activities from this
proposal, I will be able to reach my long-term goal of becoming an independent translational investigator using MRI to
infer key metabolic, biological, and physiological characteristics of cancer pathogenesis based on metal homeostasis.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is ranked as the fourth leading cause of cancer-related death in the United States with 1 -and 5-year survival rates of 20% and 7%, respectively. It is known that in pancreatic cancer zinc storage and transport is dysregulated, and that the level of dysregulation follows malignant progression. This work proposes a non-invasive technique to detect early malignant transformations in pancreatic cancer using a MRI zinc sensor. This approach based on MR imaging of zinc content and secretion places this proposal in a unique position to revolutionize the diagnostic paradigm of pancreatic cancer in the clinic.